Investigating the role of pericytes as regulators of breast tissue homeostasis and cancer.

PROJECT SUMMARY
Despite advancements in clinical treatment and screening, breast cancer remains the second most
deadly and most frequent cause of cancer in women. BRCA1 related cancer is associated with dramatically
increased risk of cancer occurrence. Most BRCA1 related breast cancers will be ‘triple-negative’, with no targeted
therapies, poor prognosis, and decreased overall survival. Pre-neoplastic changes in BRCA1 mutation carrier
epithelium have been well studied, as well has the tumor microenvironment. However, BRCA1 germline
mutations are likely to affect all cells in the breast, not just the epithelium. Less well studied, and the focus of this
proposal, are the pre-neoplastic changes that occur in the stromal cells of the breast microenvironment, and their
contributions to cancer initiation. The overarching hypothesis of this proposal is that the breast microenvironment
is distorted by BRCA1 mutations and contribute to cancer initiation.
A persistent challenge in assaying the stroma of the breast microenvironment is the diversity and
heterogeneity of this tissue compartment. To overcome this challenge, our lab has performed single cell RNA
sequencing (scRNAseq) of 81,023 stromal and epithelial cells from a cohort of high-risk BRCA1 mutation carrier
and control patient surgical breast samples. scRNAseq has the resolution to identify specific cell populations in
the breast microenvironment and how they change in the preneoplastic microenvironment. Using this highly
multidimensional data, this proposal aims to 1) describe altered paracrine interactions in the pre-neoplastic
breast and to 2) identify how microenvironment composition may be distorted in BRCA1 mutation carrier breasts.
Using scRNAseq and in vitro organoid models, preliminary work has defined a pro-proliferative paracrine
interaction of pericytes with basal epithelium. Additionally, this study uses scRNAseq data to develop a novel
flow cytometry strategy to specifically isolate pericytes to demonstrate that pericytes have multipotent
mesenchymal potential. This study proposes that these multipotent pericytes may serve as the stromal
mesenchymal stem cell progenitor. To assess how these interactions contribute to breast cancer initiation, this
study proposes two in vivo humanized mouse models that allow growth of oncogenic patient breast epithelium
with defined patient-derived stromal populations. If successful, this study will provide insights into paracrine
interactions that have been previously undefined but may have roles in breast cancer initiation. Furthermore,
identification of a stromal progenitor may yield new biomarkers and targets for high-risk breast cancer.

Public health relevance
PROJECT NARRATIVE Women who carry a BRCA1 mutation have significantly increased risk of developing aggressive breast cancer with poor prognosis. While pre-neoplastic changes in the BRCA1 mutated mammary epithelium have been well studied, the effects of BRCA1 mutations on the mammary microenvironment have gained less attention. By investigating functional hypotheses generated by single cell RNA sequencing, this study aims to understand the role of pericytes as microenvironment regulators of BRCA1 related breast cancer initiation.